Genetics Core

GENETICS CORE SUMMARY
This new application will build on our work of the three previous funding cycles in which we established the
Human Genetics Core (HGC) as an essential part of the Columbia ADRC. The HGC provides a centralized
resource for the organization and analysis of genetic data within the ADRC and projects affiliated with the ADRC
at Columbia University by providing the full physical and intellectual infrastructure needed to coordinate genetic
research efforts and provide a platform for investigators to create a better understanding of genotype-phenotype
relationships for dementia and related endophenotypes.
Specifically, the HGC will: (1) provide a genetic material repository to process, extract, store and distribute
genetic material from patients and controls, and track the collection and usage of genetic material; (2) provide
a genetic database for storage, handling, preparation and distribution of genomic data from ADRC subjects and
large-scale datasets available to the ADRC; (3) provide a high-end cluster environment and analytical
support in statistical genetics and bioinformatics to facilitate genomic data analysis; and (4) extend the largescale
genomic data available on this ADRC sample (ie. GWAS, WGS/WES, eQTL maps), and comprehensively
characterize subjects for genetic variation in the amyloid, tau, immune response, and endosomal trafficking
pathways as well as genetic ancestry. In line with our vision for precision medicine, this characterization will
move us forward to i) provide investigators with a backbone for more targeted research informed by genetic
background, ii) disentangle potential pathophysiologic heterogeneity in this cohort, and iii) explore a variety of
critical questions addressing the Thematic Aim by integration with the extensive translational data generated by
the Neuropathology, Biomarker and Neuroimmunology Cores.